Clinical Research Training in Schizophrenia and Other Psychoses

Abstract
This clinical research training program emphasizes developing research scientists who focus on schizophrenia
and other psychotic disorders. It particularly emphasizes training in cognitive and affective deficits in psychotic
disorders, influences on clinical and functional outcomes, and intervention research to improve clinical and
functional outcomes. Training will include core didactic coursework and direct experiences in designing and
conducting clinical research with patients with psychotic illnesses, including randomized clinical trials to
evaluate efficacy of interventions and research into mechanisms of action of interventions. Direct mentoring by
clinical investigators and other scientists and statisticians is a key feature of this program, with the focus being
on development and implementation of clinical research with individuals with schizophrenia, severe mood
disorders, and other psychotic disorders and those at risk for such disorders.
This postdoctoral training program will focus on individuals with Ph.D. in clinical psychology and those with an
M.D. followed by a psychiatry residency. In addition, individuals with a Ph.D. in cognitive or affective
neuroscience and similar fields who focus on research on psychotic disorders will be welcomed. The training
program includes (1) extensive hands-on training in the development and implementation of clinical research
on cognitive and affective factors in outcomes and on interventions to improve clinical and functional
outcomes, (2) a weekly Research Seminar on the Psychoses taught jointly by clinical researchers and other
scientists focused on research methods, recent research results, and grant preparation issues, (3) a set of core
courses in research design, statistics, and implementation of clinical trials and other clinical research, (4) other
coursework, workshops, and laboratory training tailored to individual research interests, (5) an intensive career
development retreat and other career development sessions, and (6) training to enhance the responsible
conduct and reproducibility of research. The training will be closely interfaced with many clinical research
opportunities that allow access to research participants with schizophrenia and other psychotic disorders.

Public health relevance
Project Narrative The enduring deficits in neurocognition, social cognition, and emotion and associated negative symptoms have been shown to be the largest contributors to everyday work and social impairment in schizophrenia and other psychotic disorders. We need to understand how these factors impact outcomes, to develop and evaluate improved strategies for targeting these mediators of outcome, and to optimize our interventions to improve clinical and functional outcome. Thus, it is of vital national health relevance to train additional researchers to focus on clinical research on psychotic disorders, including experimental therapeutic approaches to targeting mechanisms and improving the efficacy of our interventions.